Duke-UNC Collaborative Pediatric Clinical Pharmacology Postdoctoral Training Program

ABSTRACT
Duke University and the University of North Carolina at Chapel Hill (UNC) have had, for the past 9 years, a
successful T32 postdoctoral training program in adult and pediatric clinical pharmacology that builds on our
exceptional research environment with world-class programs in pediatric drug discovery, drug development,
pharmacokinetics/ pharmacodynamics, and drug safety. This new application aims to secure continued funding
of pediatric positions for the pediatric clinical pharmacology training program component. The demand for
pediatric clinical pharmacologists is high, and we have an outstanding track record of training clinician-
scientists, including pediatricians, to meet the growing workforce needs in this field. We have an excellent and
diverse applicant pool with many more qualified applicants than funded positions. This new application
describes our 2-year training program (3 trainees/year), which offers strong leadership, internationally-
recognized mentors from multiple disciplines who are actively involved in pediatric clinical pharmacology, a
wide-array of cutting edge technologies and resources, and a uniquely collaborative environment with strong
institutional support. The national applicant pool for this program is derived primarily from MDs in pediatric
medical specialty training programs seeking a career path in pediatric clinical pharmacology, and also from
PharmDs in advanced clinical/translational research training. Trainees, guided by individualized development
plans and mentoring teams, complete pediatric clinical pharmacology coursework and engage in program-
specific activities to gain expertise in all aspects of contemporary pediatric clinical pharmacology research in
preparation for successful academic, regulatory or industrial careers as leaders and mentors to future
generations of pediatric clinical pharmacologists. Experienced faculty mentors are chosen based on their
research productivity in at least one of four focus areas that form the core of this training program: Drug
Disposition and Action; Quantitative Pharmacology/Pharmacometrics & Clinical Trial Design; Individualized
Therapy; Drug-induced Organ Toxicity. Novel components of this pediatric training program include an
increased focus on precision dosing, use of real-world data, and pharmacometrics; pilot programs to expand
pediatric clinical pharmacology training in specialty and innovative areas including pregnancy and lactation;
enhanced professional development opportunities; and expansion of collaborations with other T32 programs. A
unique feature of this training program is the strength in pediatric pharmacometrics training. The keen interest
in pediatric clinical pharmacology within our trainee pool, the unparalleled investment in pediatric clinical
pharmacology research resources at Duke and UNC, the intellectually-rich biomedical science environment of
Research Triangle Park, and our longstanding excellent research and training infrastructure combine to create
a moment of unsurpassed opportunity for training in pediatric clinical pharmacology.

Public health relevance
Over the past two decades, there has been an explosion in pediatric clinical studies requiring a deep understanding of pediatric clinical pharmacology. This has provided unprecedented opportunities in pediatric drug development and clinical pharmacology training. The proposed program will produce diverse pediatric clinical pharmacologists that will be well-trained to lead the efforts in pediatric drug development.